REAL-TIME SURVEILLANCE OF VACCINE MISINFORMATION FROM SOCIAL MEDIA PLATFORMS

To develop digital tools to identify and combat malicious digital bots that spread misinformation about infectious disease treatments and vaccines, including COVID-19 vaccines.